Determining the Role of Replication Protein A in Polymerase Theta-Mediated End-Joining

PROJECT SUMMARY
Many frontline cancer treatments, including radiation therapy and several chemotherapeutics, work by inducing
double-strand breaks (DSBs) since cancer cells are typically more vulnerable to DSBs than healthy cells. Thus,
understanding the complex pathways cancer cells use to repair DSBs is critical to understanding and
addressing resistance to these therapeutic agents, which almost invariably arises. Deficiencies in the high
fidelity DSB repair pathway homologous recombination promote tumorigenesis. The resulting cancers are
dependent on a mutagenic DSB repair pathway called polymerase theta-mediated end-joining (TMEJ).
Polymerase theta (Polθ) is a multifunctional enzyme consisting of an N-terminal helicase domain, disordered
linker domain and C-terminal polymerase domain. Polθ is essential for TMEJ, but the other factors involved in
this pathway remain poorly defined. While genetic screens have revealed several non-essential proteins that
may play a role in TMEJ, these screens are incapable of identifying essential factors that interact with Polθ to
promote TMEJ. In this proposal, I will determine the role of the essential, eukaryotic single strand DNA-binding
protein, replication protein A (RPA), in TMEJ. Based on partial knockdown in cells, RPA was initially thought to
inhibit TMEJ.1 However, when I depleted RPA from a cell-free TMEJ assay in Xenopus egg extracts, end-
joining was abolished. TMEJ was rescued with recombinant RPA, demonstrating that RPA is essential for
TMEJ. The deep learning tool Alpha-Fold Multimer predicts that RPA and Polθ interact via two interfaces —
one on RPA1 and one on RPA2. When I mutated these interfaces on RPA, replication was unaffected but
TMEJ was inhibited. Mutating the corresponding residues on Polθ also abolished TMEJ. I hypothesize that
these interfaces are necessary for Polθ recruitment and annealing of microhomologous regions. In Aim 1, I will
test the hypothesis that RPA1 binds and recruits Polθ and that this allows Polθ to bridge two non-homologous
strands. In Aim 2, I will test the hypothesis that RPA2 promotes TMEJ by stimulating the helicase domain of
Polθ to simultaneously bind DNA, anneal two distinct strands and destabilize and remove RPA. Understanding
the role of RPA in TMEJ will provide fundamental insight into how Polθ interacts with other proteins to repair
DSBs both in health and disease.

Public health relevance
Project Narrative: This project will determine the role of the eukaryotic single-strand DNA binding protein RPA in regulating polymerase theta-mediated end-joining, a mutagenic repair pathway that is upregulated in many cancer cells. Understanding the molecular mechanism of this pathway will allow us to better target it in cancer therapies.